Ligand-Induced Recruitment of CAR-T Cells to Colorectal Cancers

PROJECT SUMMARY
Among the most powerful and successful new therapies to enter the cancer clinic is CAR-T cell therapy. CAR-
T cell therapy has been remarkably effective for patients with certain refractory, progressive hematologic
cancers, resulting in several FDA-approved CAR-T cell therapies. However, this therapy has not been
successful for solid cancers, such as colorectal cancer (CRC), reflecting the need for suitable antigen targets
for each disease, as well as patient, tumor, and immune factors, especially poor infiltration of solid tumors by
CAR-T cells. The development of cellular therapies that can be applied to CRC without toxicity would have a
remarkable impact on the landscape of solid cancer therapy.
Here, we test the hypothesis that CAR-T cells can be engineered to home to CRC tumors by leveraging their
endogenous chemokine milieus, increasing antitumor efficacy over conventional CAR-T cells. We have
identified a chemokine + chemokine receptor axis that maintains an immunosuppressive tumor
microenvironment (TME) in CRCs. Using validated human CRC models and target antigen, we will engineer
CAR-T cells to express the chemokine receptor directed at this CRC chemokine and explore the safety and
efficacy of this approach in mouse models. Aim 1 will define the tumor homing and efficacy of chemokine
receptor-engineered CAR-T cells in vitro and in vivo using human CRC cell lines. Aim 2 will define the safety
impact in mice because this approach may increase homing of CAR-T cells to not only tumors but also normal
tissues, resulting in toxicity. Together, these studies will produce the necessary proof-of-concept data to
develop this therapeutic approach for translation to clinical trials in patients with advanced/metastatic CRC.

Public health relevance
PROJECT NARRATIVE Failure of transferred immune cells to travel to and infiltrate tumors is a leading cause of failure for adoptive immune cell therapies. Here, we will engineer immune cells to express “homing” molecules to direct these cells to colorectal cancer and overcome this limitation. We will use laboratory models to see if this approach is safe and effective in animal models with the long-term goal of creating a safe and effective therapy for colorectal cancer patients.